Gene Transfer to DRG to enhance sensory recovery in spinal cord injury

? DESCRIPTION (provided by applicant): This project is designed to advance the understanding of axon regeneration in the context of cervical spinal cord injury (SCI) and to evaluate a novel approach to enhance recovery. Our published work demonstrate that following trauma to the dorsal (sensory) root that gene transfer to dorsal root ganglion (DRG) neurons using nonreplicating recombinant herpes simplex virus (HSV)-based vectors can enhance sensory axonal regeneration and that HSV-mediated gene transfer to the DRG can reduce below-level neuropathic pain following SCI and after proximal root injury. The proposed study will exploit advances in our laboratory in the development of recombinant non-replicating genomic HSV-based vectors for gene transfer to the nervous system to test the hypothesis that HSV-mediated delivery of C3 transferase gene alone or in combination with the gene for the neurotrophin artemin to the DRG from skin inoculation can be used to enhance sensory axon regeneration and improve sensory behavioral outcomes after cervical SCI, thereby mitigating functional disability. The experiments outlined in this proposal exploit the unique properties of HSV-based vectors to provide local delivery of bioactive peptides to the extending tip of injured axons. These studies will advance understanding of the basic biology underlying recovery in SCI while testing a therapeutic intervention that could be applied to the treatment of Veteran patients.

Public health relevance
PUBLIC HEALTH RELEVANCE: Spinal cord injury (SCI) causes high prevalence of severe neurologic disabilities due to the failure of axonal regeneration and the development of chronic neuropathic pain, research to develop novel therapeutic strategies for SCI patients has been designated as a priority by the VA. We are proposing to use gene transfer to the sensory neurons of the DRG by a HSV-based vector delivered by subcutaneous inoculation to enhance sensory axonal regeneration following SCI and to measure sensory-motor and pain behaviors. We have taken a different HSV vector construct to Phase 1 and 2 clinical trials for cancer pain and found the vector to be safe, and we are moving towards using similar approach in neuropathic pain in patients with diabetes. The studies proposed are designed to develop preclinical evidence, and if successful, would provide proof-of-principle for a platform technology that could be extended to treat SCI patients.